Circadian Mechanisms of Hedonic Feeding in Obesity

Project Summary
The circadian clock is an auto-regulatory transcription feedback loop present in the brain and peripheral tissues
that coordinates sleep/wake and physiology in anticipation of the rising of the sun each day. Epidemiologic,
clinical and genetic studies have shown clock dysregulation contributes to both obesity and its metabolic co-
morbidities. Recently, we have shown that abrogation of the core molecular clock component BMAL1 in
hypothalamic hunger neurons leads to increased feeding at the wrong phase of the day/night cycle and causes
impaired glucose tolerance, a hallmark of diabetes. AgRP neuron transcriptomics further identify circadian
regulation of dopaminergic neurotransmitter synapse, indicating that clock disruption may lead to alterations in
both the hedonic and homeostatic control of feeding. With a focus on understanding the mechanisms linking
circadian systems to hedonic feeding, I have generated new data demonstrating that disruption of the molecular
clock in dopaminergic neurons of the classical reward-promoting ventral tegmental area (VTA) results in
hyperphagia of palatable high fat food and accelerates diet-induced obesity, hyperglycemia, impaired oxidative
metabolism by respirometry, altered sleep patterns, and decreased daytime open field behavior. The scientific
rationale underlying my present proposal is that the circadian clock modulates time-of-day dependent feeding
and metabolic processes through the regulation of food-associated reward within midbrain dopaminergic
neurons. This proposal seeks to contribute new insight into how neuronal clocks synchronize behavioral and
transcriptional rhythms to impact physiology, findings which have broad implications for the treatment and
prevention of sleep-loss related disorders of obesity, metabolic syndrome, and type 2 diabetes mellitus.

Public health relevance
Project Narrative The pandemics of obesity and metabolic syndrome have increased concurrently with the spread of late-night shiftwork, circadian disruption, and sleep deprivation associated with 24/7 lighting and labor demands of global industrialization; however, our understanding of the molecular pathophysiology linking sleep and circadian disruption with metabolic disease remains in its infancy. The present proposal seeks to dissect the novel hypothesis that the intrinsic circadian clock, programmed by an autoregulatory transcription feedback loop, plays a primary role in the control of feeding behavior and metabolism throughout the sleep/wake cycle and that disruption of this system contributes to metabolic disorders. My specific focus will be to dissect the novel hypothesis that molecular clocks synchronize reward behavior and feeding with sleep through actions in the appetitive center of hypothalamus and linked regions of the dopaminergic ventral tegmental area where I will exploit a combination of genetic, behavioral, physiological and genomic strategies to test the hypothesis that western diet-highly palatable food leads to disruption of hedonic and homeostatic feeding ultimately opening novel rational therapeutics for metabolic complications of sleep loss and circadian disorders in humans.